Feasibility Trial of a Remotely-Delivered Mindfulness-Based Intervention for Adolescents with Migraine

PROJECT SUMMARY/ABSTRACT
The goal of the proposed K23 Career Development Award is to provide the PI with the mentorship, knowledge,
and skillset to develop into a patient-oriented independent investigator studying scalable, accessible behavioral
and mind-body interventions for youth with migraine and other pain conditions. The mentoring team will provide
the PI with training in randomized clinical trials, implementation science, and mind-body interventions. The
training is integrated in a research proposal and planned clinical trial evaluating a remotely-delivered
mindfulness-based intervention (MBI) group program adapted for adolescents with migraine. Migraine is the
second leading cause of disability worldwide. Negative affectivity (depression, anxiety) is associated with worse
pain-related disability and is particularly prevalent in the adolescent developmental period. Existing
pharmacological and behavioral interventions for adolescent migraine do not target or change negative
affectivity, are difficult to access, and for pharmacological intervention, are often no more effective than placebo.
Scalable and accessible approaches that target negative affectivity may yield more efficacious treatment and
reach more patients in need. MBIs hold promise to consider these needs. However, minimal research has studied
MBIs for adolescents with migraine and none have considered patient-centered adaptations or designing for
dissemination principles. The PI’s preparatory work for this K23 focused on Phase I (Design) of the ORBIT Model
for Developing Behavioral Treatments for Chronic Diseases framework. In this phase, the PI adapted and
refined a virtual group-based MBI to meet the unique needs of adolescents with migraine in partnership with
interest holders (patients, parents, providers). Now for ORBIT Phase II (Preliminary Testing), the PI proposes a
pilot feasibility randomized trial to test the feasibility and acceptability of the adapted intervention, BREATHE-
Headache (BREATHE-HA) and Enhanced Standard-of-Care (attention-matched virtual, group headache
education program) in 72 adolescents with frequent migraine (Aim 1). Parallel implementation science work will
assess potential facilitators and barriers to implementation of virtual group-based interventions (like BREATHE-
HA) in tertiary care settings (Aim 2) to bridge the translational science-to-practice gap. If this pilot study meets
pre-determined feasibility and acceptability targets, it will provide a strong platform for the PI to undertake an
adequately powered, hypothesis-testing pragmatic clinic-based efficacy trial in a future R01. Together, this work
will provide a critical foundation for the PI to advance efficacy of and access to evidence-based behavioral and
mind-body interventions for youth with migraine and chronic pain.

Public health relevance
PROJECT NARRATIVE Migraine is the second leading cause of disability worldwide, yet treatment is difficult to access, and often ineffective in adolescence, a period in which migraine prevalence dramatically rises. This study will assess the feasibility and acceptability of a virtual, group mindfulness-based intervention for adolescents with migraine, designed with direct patient input and future dissemination in mind. If the efficacy of this virtual program for improving pain-related disability is confirmed in a future efficacy trial, it could offer an accessible, nonpharmacological option for adolescents with migraine to prevent long-term migraine disability and promote emotional and physical wellbeing.